State-dependent modulation of olfactory behavior

Project Summary
Hunger and thirst are powerful motivational states that drive intense attraction to need-related stimuli. Here, we
investigate how hunger and thirst differentially focus behavioral attention towards food and drink odors but not
other olfactory cues. These studies should help provide insight into long-standing questions in neuroscience,
including how various sensory inputs are distinctly represented in the brain, and how physiological state
influences behavior. The olfactory system detects a myriad of odors that elicit diverse perceptions, and in mice,
food odors, pheromones, and predator odors differentially influence feeding, mating, and fear. One model is
that the olfactory system uses parallel processing streams to channel particular sensory inputs into appropriate
behavioral outputs. Interestingly, hunger and thirst influence only select olfactory pathways, enhancing
attraction to food and drink odors respectively but not pheromones. Yet, molecular and cellular features that
distinguish olfactory circuits responsive to food or drink odors are unknown. Here, we will leverage powerful
genetic approaches in mice to study how hunger and thirst selectively and differentially gate odor responses.
We recently observed that hunger shifts odor preference through a Neuropeptide Y (NPY) spotlight (Nature
2021). Optogenetic stimulation of hypothalamic AGRP (Agouti-related peptide) neurons, like fasting, promotes
attraction to food odors but not pheromones through specific projections to the paraventricular nucleus of the
thalamus (PVT). Knockout mice lacking NPY or one of its receptors (NPY5R) fail to prefer food odors over
pheromones after fasting, with normal behavior restored by cell-specific NPY rescue or acute NPY injection in
the absence of further training. Thus, food odor-responsive neurons comprise an olfactory subcircuit that
listens to hunger state through thalamic NPY release. Here, we will build off of these findings by using NPY5R
as a genetic handle to characterize key neurons involved in food odor responses. Npy5r mRNA is highly
expressed in olfactory (piriform) cortex but not PVT, and NPY5R neurons from the piriform cortex are back
labeled by tracer injection in the PVT. We hypothesize that NPY5R acts in PVT-projecting axons of food odor-
responsive cortical neurons. We made new mouse models for Cre-based knockout and rescue of the Npy5r
gene to pinpoint the site of NPY5R action, as well as Npy5r-p2a-Cre mice to enable optogenetics and fiber
photometry experiments. Moreover, in preliminary data, we developed a paradigm to measure thirst-driven
odor attraction, and are poised to chart how thirst and hunger exert differential control over olfactory
responses. Together, these Aims should help reveal how neural circuits represent different classes of olfactory
cues and mediate state-dependent behaviors.

Public health relevance
Project Narrative Neuronal mechanisms that control selective behavioral attention to sensory cues have been a long-standing mystery. Hunger is a powerful motivational state that enhances attraction to food odors but not other olfactory cues through a Neuropeptide Y spotlight; thirst instead enhances attraction to drink odors, but neuronal mechanisms involved remain mysterious. Here, we leverage key molecular features of olfactory subcircuits to investigate (1) how various sensory inputs are distinctly represented in the brain, and (2) how two distinct physiological states- hunger and thirst- differentially influence sensory responses.